Development of TACA Glycan Library and Related Glycomics Products

Project Summary/Abstract:
Tumor-associated carbohydrate antigens (TACAs) are aberrantly expressed glycans associated with cancer
cells, playing critical roles in cancer progression and immune evasion. Despite their potential as diagnostic and
therapeutic targets, the lack of comprehensive tools to study TACA interactions has significantly limited progress
in this field. This project addresses these challenges by developing the first comprehensive TACA glycan library
and glycan array, integrating 58 existing TACAs with 22 newly synthesized glycans and glycopeptides for MUC16
(CA125), sTRA, and sLeA. These newly synthesized TACAs enable detailed exploration of the glycoform-specific
interactions of MUC16, sTRA, and sLeA. The TACA glycan array will feature TACAs displayed at varying
densities and valencies, simulating the diverse glycan presentations found on cancer cells. This innovative
design allows for the systematic evaluation of TACA interactions with therapeutic antibodies, biologics, and
glycan-binding proteins. By providing tools to study these interactions under biologically relevant conditions, the
project aims to advance the development of TACA-targeted diagnostics and therapeutics. Phase I focuses on
developing and validating the TACA library and associated array, leveraging Z-Biotech’s expertise in glycan
synthesis and array fabrication. The amine-tagged TACAs, both pre-existing and newly synthesized in this project,
will also support broader applications, such as conjugation to fluorescent beads for autoantibody screening.
Phase II will expand the library to include over 300 TACAs and further refine the array for commercial deployment.
This initiative will accelerate the discovery of new TACA-targeted diagnostic and therapeutic candidates,
establish a transformative research resource, and deepen our understanding of TACA-mediated cancer biology.

Public health relevance
Project Narrative: This project aims to develop the first comprehensive TACA glycan library and associated glycan array, addressing critical gaps in studying tumor-associated carbohydrate antigens (TACAs). These tools will accelerate the development of TACA-targeted diagnostics and therapeutics, improving early detection and treatment of cancers. The resulting platform will have broad implications for cancer research as well as cancer diagnostic and therapeutic development.